15-hLO-1 inhibitors as Potential Therapeutics Against Stroke

During this period, the NCGC worked to further characterize previously identified potent and selective 15-hLO-1 inhibitors (ML094 and ML351) in cellular and animal models, to identify their binding mode and improve their formulation. As a center, the NCGC has fostered and maintained over 110 active collaborations with both NIH and extramural investigators, facilitating drug discovery efforts across the entire spectrum of human disease. These efforts have led to dozens of high-throughput screens and a number of medicinal chemistry campaigns to further improve on screening hits, providing our collaborators and the general research community with publications and a variety of promising small molecule probes and leads. In addition, the NCGC has worked to advance a number of informatic initiatives to make better use of existing drug and disease target information and provide the general public with easily accessible resources, further catalyzing the development of new therapies for human disease.